TO PROVIDE THE DENOMINATOR DATA REQUIRED FOR THE NCI TO RELEASE CANCER RATES BY SINGLE RACE AND ETHNICITY AMONG IMMIGRANTS AND EASY-TO-ACCESS ACS SAMP

The study of racial disparities in cancer incidence and mortality rates among immigrants requires population data by immigration status and single-race categories. The American Community Survey (ACS) is the only authoritative data source for estimating populations, as immigration status is not collected in the decennial censuses. However, ACS race data needs to be bridged into a single-race format for ACS-based populations to be usable for calculating cancer rates. A previous contract with the University of Minnesota (Contract number: HHSN 75N91019P00786) has developed a race-bridging method and produced annual population estimates by single-race and immigration status for 2005-2017. This contract builds on this previous contract to extend the population estimates to future years and integrate the newly developed single-race variable into ACS samples from 2005 to 2019 in a data-inquiry system that UM has developed to called IPUMS to allow extracting single-race population by other risk factors. The Department of Health and Human Services, National Institutes of Health (NIH), National Cancer Institute (NCI), Division of Cancer Control and Population Sciences (DCCPS), Surveillance Research Program (SRP) requires population estimates by single-race and nativity (i.e. US-born and foreign-born) for 2018-2019 calculated using individual level data from the American Community Survey (ACS). The deliverables provided under the subsequent purchase order will provide the denominator data required for the NCI to release cancer rates by single race and ethnicity among immigrants, and easy-to-access ACS samples that the NCI will be able to use to generate population estimates by alternative specifications.